Environmental Determinants, Maternal Postpartum Depression, and Mental-Emotional-Behavioral Disorders in Urban-Dwelling Children

The overarching goal of this application is to identify environmental factors contributing to the rising mental-emotional-behavioral (MEB) disorders in urban-dwelling children and parental postpartum depression (PPD) in Southern California, and strengthen their respective causal associations. MEB disorders are prevalent among urban-dwelling children and adolescents, causing detrimental and long-lasting impacts on affected individuals and their families. Increased frequencies of MEB disorders have been observed in Southern California; the trend cannot be explained by diagnostic practices alone, yet it tracks well with the concurrent increases in maternal PPD and extreme weather change in Southern California. We hypothesize that neurotoxic environmental exposures increase risks for parental PPD, both contributing to the rising MEB disorders in children and adolescents. The environmental factors of primary interest are extreme heat and wildfire fine particulate matter (PM2.5) and polycyclic aromatic hydrocarbon (PAH). We will examine the effects of both short-term (daily to weekly) and long-term (monthly to yearly; across seven life stages from pre-conception up to adolescence) exposures. Despite strong scientific premises on the effects of extreme heat and wildfire smoke on increasing the risk of parental PPD and child MEB disorders, epidemiologic data remain elusive on linking environmental exposures with adverse mental health in children, and the role of parental PPD in mediating and/or confounding the effects of environmental exposures on MEB health is unclear. The extant literature suffers from several major methodological limitations, lacking high-quality clinical outcome data and missing participant-level exposures estimation particularly for exposures to PAHs from wildfires. This study will address these knowledge gaps and methodological weaknesses by leveraging an established longitudinal pregnancy cohort (2008-2021) based on the comprehensive electronic health record (EHR) of Kaiser Permanente Southern California (KPSC). Children’s MEB outcomes and maternal PPD have been validated. This study will extract relevant paternal data plus 4 more years of birth data (2008-2025; ~600,000 births), continue the outcome follow-up to 2027, and expand the scope of exposure assessment. Spatiotemporally-resolved exposures (extreme heat; wildfire-specific PM2.5 and PAHs) mapped on longitudinal residential histories (from pre-gestational to age 17) will be combined with prospectively recorded and high-quality data on clinical phenotypes, comorbidities, and other relevant covariates. Four aims will respectively focus on MEB disorders (Aim 1), parental PPD (Aim 2), the role of PPD in the putative associations of MEB disorders (Aim 3), and effect modification by neighborhood socio-environment and individual-level factors (Aim 4). This application is highly significant as MEB disorders in children are pressing public health issues. We will advance environmental neurosciences by quantifying the impacts of extreme heat and wildfire smoke on children’s MEB health and parental PPD, clarifying their causal associations including the role of PPD, identifying susceptible time windows, and determining the social-environmental vulnerability.

Public health relevance
. Environmental stressors pose serious threats to mental health, and yet the clinical and public health science communities are in the early stage of defining the precise nature and risks caused by specific exposure pathways. This longitudinal birth cohort study, built on high-quality clinical data of urban-dwelling population in Southern California, aims to quantify the impacts of environmental factors (i.e. extreme heat and wildfire smoke) on the rising rates of parental postpartum depression (PPD) and adverse mental-emotional-behavioral (MEB) disorders in offspring, the role of PPD in mediating and/or confounding the effects of environmental exposures on children’s MEB outcomes, and effect modification by individual- and neighborhood-level socioeconomic factors. The impact of this research is high, given the critical importance of addressing mental health challenges in the U.S., now and for future generations.